LONG-ACTING INTERFERON FOR VIRAL DISEASES AND CANCER

Alpha interferon comprises a family of leukocyte-derived cytokines that exhibit antiviral, antiproliferative and immunomodulatory effects on many cell types. Recombinant human alpha-interferon is used to treat a variety of viral diseases and cancers and had world-wide sales in excess of $ 1.4 billion during 1994. We propose to create modified alpha-interferon proteins that are equal or superior to natural alpha- interferon at modulating immune responses and viral and cell proliferation in vivo, but which require less frequent dosing, on the order of once per week or once every other week, rather than daily. During Phase we will identify sites in alpha-interferon that can be modified without affecting the protein's in vitro bioactivity. During Phase Il, we will develop manufacturing processes to produce sufficient quantities of the modified ex-interferon proteins for testing in animal models of cancer and viral diseases. The improved characteristics of the novel alpha-interferon proteins should reduce the amount of alpha-interferon required per patient, reduce toxicity, improve patient compliance and quality of life and result in considerable cost savings to patients and healthcare providers. alpha- interferons are members of a large family of structurally related growth factors and cytokines. Information gained from these studies will aid in creating long-acting versions of other members of this gene family for use in treating cancer, infectious disease and hematopoietic disorders. PROPOSED COMMERCIAL APPLICATIONS: Recombinant human alpha-interferon is used to treat a variety of viral diseases and cancers and had world-wide sales in excess of $l.4 billion in 1994. The modified alpha-interferon proteins under development will require much less frequent dosing than existing alpha-interferon products, resulting in significant cost savings to patients and healthcare providers. Additional benefits may include improved drug efficacy, reduced toxicity and improved patient quality of life.